Pediatric Heart Network Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
The Pediatric Heart Network (PHN) is a cooperative network of Core and Auxiliary Clinical Centers, a DCC, and
National Heart, Lung and Blood Institute (NHLBI) Project Scientists. New England Research Institutes (NERI) is
applying to continue its 22-year role as the Data Coordinating Center (DCC) for the PHN. The objectives of the
PHN DCC are to 1) coordinate and manage the PHN infrastructure to ensure PHN goals are met; 2) collaborate
to execute PHN studies and trials; 3) disseminate PHN data and results; and 4) create a platform for early-stage
investigator training and development. As the DCC, NERI will provide robust scientific oversight and proven
logistical support for the next cycle of the Network. Key responsibilities and functions include leadership in project
management of the Network, overall study coordination and efficient management of data acquisition; leadership
in development and deployment of innovative infrastructure and tools, electronic information and data systems;
logistical and support services; novel study design and statistical methodologies; and management and
distribution of Network funds. Our proposed approach presents a strong, experienced team, which builds upon
decades of successful close collaboration with NHLBI and ensures efficient scientific and administrative support
to the PHN, using 21st century technologies.
A multiple PI leadership plan is proposed to continue the leadership roles shared by Ms. Miller (Network
Operations) and Dr. Trachtenberg (Statistics), with clearly delineated roles and responsibilities for leading and
directing the DCC.

Public health relevance
PROJECT NARRATIVE The mission of the Pediatric Heart Network is to improve health outcomes in individuals of all ages with congenital heart disease or pediatric acquired heart disease; through clinical trials and other clinical studies; disseminate collaborative findings as the basis for improved evidence-based treatment options and standards of care; train and educate new investigators and provide support and advocacy for families during the conduct of excellent, ethical clinical research. The Data Coordinating Center provides the network infrastructure to support this research.